Mechanisms Underlying Tissue Fragility in Ectodermal Dysplasias

TP63 is a transcription factor required for the normal development and homeostasis of the skin.
Missense mutations in the TP63 gene are linked to a subset of severe developmental disorders,
termed ectodermal dysplasias. Our application focuses on two of these, ankyloblepharon
ectodermal dysplasia and clefting (AEC) and ectrodactyly ectodermal dysplasia and clefting
(EEC), as they are each associated with severe skin erosions. Although EEC has historically not
been associated with skin abnormalities, they do occur in a subset of patients (we refer to these
patients as EEC/S patients). It is currently not clear how TP63-AEC or TP63-EEC/S mutations
lead to the observed skin defects, specifically abnormalities in keratinocyte differentiation, cell-
cell adhesion, and cell-extracellular matrix adhesion. While a few deregulated genes associated
with AEC have been described, essentially nothing is known regarding the disease mechanism
underlying EEC/S. The main goal of this application is to elucidate the cellular and
molecular defects underlying AEC and EEC/S and to expand our understanding of
the role of TP63 in normal keratinocyte biology. Based on our preliminary data, we
hypothesize that desmosomal adhesion and hemidesmosomal adhesion are impaired in AEC and
EEC/S patient skin, leading to the observed skin fragility. Further, our results suggest that
impaired desmosomal signaling contributes to epidermal differentiation defects in patient skin.
The current proposal will establish mechanistic insights into the molecular pathology underlying
skin fragility in TP63-related ectodermal dypslasias. Further, we will gain new insights into the
epidermal function of TP63, which will broaden our understanding of skin biology in general.

Public health relevance
This application focuses on a group of inherited skin disorders termed ectodermal dysplasias. The ectodermal dysplasias investigated here are caused by mutations in a master regulator of skin function, the transcription factor TP63. The main goal of this application is to understand the mechanisms by which TP63 mutations cause severe and currently untreatable skin disorders, especially skin fragility. The long term goal is to develop new approaches to effectively treat these disorders.